Reverse Engineering High Yield Lasso Peptide Production by a Burkholderia Heterologous Host

ABSTRACT
Lasso peptides are bacterial metabolites characterized by a unique knotted configuration that confers thermal
stability, proteolytic resistance, and potent target affinity in biological applications. Known lasso peptides have a
diversity of biological functions, including as antibiotics. In terms of modification for drug development, they are
recognized for their ability to be engineered via epitope grafting and genetically encoded libraries. However, the
lack of a viable platform to produce lasso peptides has hindered the discovery and development of lasso-based
drug leads. Chemical synthesis of lasso peptides is impeded by the lasso fold, positioning microbial production
as a favorable alternative. However, heterologous expression of lasso peptide gene clusters (most commonly
using E. coli as the bacterial host) results in low yield (<15 mg/L). In an experiment to test the expression of the
model lasso peptide capistruin in an alternative Burkholderia bacterial host, a stochastic overproducer clone was
identified. Preliminary investigation into the underlying molecular mechanisms of capistruin overproduction led
to the recapitulation of high yield capistruin production (up to 130%) by way of plasmid copy number modulation.
Production of capistruin with this alternative Burkholderia host corresponds to a yield 800-fold greater than that
reported for production using E. coli. Our production platform was validated when Burkholderia was employed
to express an orphan gene cluster from the endosymbiont Mycetohabitans sp. B13 (Burkholderiaceae), leading
to the discovery of two lasso peptides. The objectives of this proposal are to further establish an effective
production platform for novel lasso peptides while simultaneously deepening our understanding of the molecular
determinants of compound overproduction by the Burkholderia host.

Public health relevance
NARRATIVE Natural product-based drugs are the cornerstone of drugs available on the market today. Genome mining and microbial engineering have consistently been efficacious tools for natural product dug discovery and development. Current advances in molecular genetics, such as fast, accurate, and affordable sequencing technologies, enable us to further tap into the potential of microbial natural products for drug discovery. These technological advances leave room for significant advancement in microbial production and engineering. Currently, there is a bottleneck in natural product drug discovery brought on by a shortage of well-studied bacterial hosts available for heterologous expression of unexplored gene clusters. The lack of diverse and well- studied host strains results in minimal yield production platforms, which limit the ability to utilize microbes for natural product drug discovery and development. The research outlined in this proposal aims to test and develop a Burkholderia bacterial host from strain FERM BP-3421, a strain proven capable of producing medicinally relevant compounds in gram per liter scale. Development of this Burkholderia strain increases the diversity of well-studied host strains available to the scientific community. Furthermore, the proposed testing of the Burkholderia host will result in the immediate production of natural products that have potential as drug leads.